GLYCOPROTEINS OF HUMAN HERPESVIRUS-6

Human herpesvirus-6 (HHV-6), the newly identified lymphotropic herpesvirus, is the etiological agent of exanthem subitum and emerging studies also suggest it's involvement in fatal hepatitis, acute and chronic hepatitis, persistent lymphadenopathy, acute mononucleosis and encephalitis. HHV-6 infects productively CD4+ human T lymphocytes, which may potentially have several important implications in human diseases. Our overall objective is to define the role of HHV-6 glycoproteins in its basic biology including in its interactions with human T cells. Our preliminary studies reveal several unique biological properties of HHV-6. HHV-6 strains show variations in their in vitro tropism, DNA restriction sites and in their reactivities with our MAbs against HHV-6 strain GS and Z-29. These properties segregated 20 HHV-6 strains into two groups, tentatively designated as HHV-6 group I and group II. Reactivities of human sera also demonstrated antigenic differences among these two groups and suggest that individuals may be infected with HHV-6 from one or both groups. Glycoproteins, gp82-gp105 complex of group I and gp185-gp210 of group II show major antigenic variations and unique structural features. Our immediate specific goals outlined in this proposal are designed to define in detail the immunochemical, antigenic, genetic and functional relationships among the two variable envelope glycoproteins of group I and group II strains and to determine the potential significance of these variations in the biology of HHV-6. 1. Monoclonal antibodies and mono-specific antibodies will be used to determine the identity, precursor-product, synthesis, structural and antigenic relationships among the polypeptides in gp82-gp105 complex of group I strain HHV-6(GS) and gp185-gp210 of group II strain HHV-6(Z-29) and their counterparts. 2. A 624bp genomic fragment encoding a part of gp82-gp105 characterized by us will be used to identify the genes encoding gp82-gp105 of HHV-6(GS) and (Z-29). Genomic and cDNA libraries of HHV-6(Z-29) constructed in lambda gt11 will be used to identify and sequence gene(s) encoding gp185-gp210 and the counterpart(s) in HHV- 6(GS. Identified genes will be sequenced, characterized and the genetic basis of variations among these glycoproteins will be determined. 3. Monoclonal antibodies, mono-specific antibodies and cloned genes will be used to examine the functions and functional relationships among these glycoproteins, their association with the inner and outer surfaces of infected cell membranes at different time post-infection and to evaluate the potential significance of variations in the biology of HHV-6. The studies outlined in this proposal are significant because these studies will lead into important insight in to the biology of HHV-6.